Developmental disruption of brain tissue oxygen regulation and deficiency of learning after neonatal anesthesia exposure

We are seeking supplemental funding to purchase an advanced electrophysiological
recording system for our project. This project studies the effects of general anesthesia on
neuronal activity and oxygen levels in the cerebral cortex, requiring continuous recording
via chronically implanted electrodes. Our existing system is old and increasingly
unreliable, and moreover, it is insufficient for our experiments, especially when multiple
kits are born simultaneously. A new system will allow us to monitor more animals
simultaneously and offer improved design and signal quality. The updated system will
reduce experimental time, ensure cleaner data, and enable better comparisons between
oxygen levels and electrophysiological signals. Acquiring the new Neuralynx system will
enhance our recording capabilities, benefiting our current and future research. We seek
additional funding to procure this system, confident in its substantial contributions to our
work.

Public health relevance
We are seeking supplemental funding to purchase an advanced electrophysiological recording system to study the effects of general anesthesia on neuronal activity in the brain.